Structural Studies of Helicobacter Pyloris Cag Type IV Secretion System

Project Abstract
The Gram-negative bacterium, Helicobacter pylori, persistently infects the stomachs of over half of the human
population. The cag Pathogenicity Island (cag PAI) of the Helicobacter pylori has been associated with severe
gastric diseases including gastric cancer. The cag PAI houses the type IV secretion system (T4SS) used by the
bacterium to secrete CagA, a protein associated with carcinogenesis. Considerable structural biology work has
been done to characterize the T4SS outer membrane core complex (OMCC). The OMCC is composed of a 14-
fold symmetrical outer membrane cap (OMC) and a 17-fold symmetrical periplasmic ring (PR), and stalk that has
yet to be structurally or compositionally characterized.
Sub-3.5 Å density maps determined using single particle cryo-electron microscopy are available for the OMC
and PR. While these structures allowed for molecular models to be built for these parts of the OMCC, there is a
lack of structural information for the stalk and the regions bridging the connections between the OMC, PR, and
stalk. Additionally, there is little understanding of how the Cag T4SS facilitates translocation of CagA across the
bacterial inner and outer membranes. I have improved both the Cag T4SS purification and vitrification steps,
increasing particle yield and our ability to visualize the stalk in the vitrified ice. Using these advances, I will
determine the structure and protein identity of the stalk, map connections between the OMCC sub-regions, and
structurally and functionally characterize actively translocating Cag T4SSs.
The results of this research will provide the first structural description of the Cag T4SS OMCC and molecular
snapshots of translocating T4SSs. This will allow me to propose a structure-based rationale for how CagA is
transported from the H. pylori cytoplasm into host cells. This work will also prove beneficial in studying other
pathogenic bacterial T4SSs such as Legionella pneumophila, Bordetella pertussis, and Bartonella species, thus
having a broader impact on medical microbiology.

Public health relevance
Project Narrative Type IV secretion systems are critical for delivery of effector proteins for the modulation of bacterial colonization environments. While there is a considerable body of research characterizing the Cag type IV secretion system of H. pylori, there has been little work defining the function and mechanism of active translocation of its effector protein, CagA, an oncoprotein. This project aims to determine the complete high-resolution architecture of the Cag T4SS with and without CagA, mid-translocation.